Spatially-resolved, integrated cell state and lineage tracing to define progenitor cell dynamics in early mouse development

Project Summary: Mammalian development is a probabilistic and robust process where progenitor cells must
integrate genetic, epigenetic, and environmental information to generate a complex body plan. The goal of this
work is to delineate how progenitor behaviors elicit specific phenotypes in health and disease. To do so, I will
leverage a technology I developed in my postdoctoral work in the Weissman lab, termed PEtracer, a prime
editing-based tool that enables the 1) assessment of cell state and lineage using both imaging- and sequencing-
based profiling methods, including spatially-resolved techniques, 2) precise perturbation of genomes for testing
hypotheses about gene function, 3) studying these processes at scale in complex tissues, in 4) a manner that
minimally affects normal cell function. To showcase the PEtracer system, I used it to study a xenograft model of
breast cancer where I reconstructed the 3-dimensional growth patterns of a primary tumor and then uncovered
how each cell’s interactions with its neighbors and microenvironment influenced its propensity to seed
metastases. These important discoveries break novel ground in cancer biology and stand to inform therapeutic
development. Here, I propose to leverage this technology in engineered mouse embryonic stem cells and mouse
models to create the first integrated maps of cell state and lineage during normal development, biological ciphers
that could be used to understand how tissues are assembled and maintained and how these processes go awry
in disease. I will use in vitro stem cell-based gastruloid models where high replication power enables a statistical
view of developmental processes and allows for perturbation studies to probe the genetic determinants of cell
state and lineage decisions in development. I will also use mouse models to study these questions in the
complete context of a developing organism.
In the K99 training phase, I will develop expertise in stem cell biology, learn how to engineer mouse models,
and sharpen computational skills needed to analyze the unique datasets these projects generate. I will learn
these technical skills from my brilliant co-mentors, Dr. Jonathan Weissman and Dr. Zachary Smith, and my
pioneering collaborators. Further, I will gain critical experience managing a growing research program during this
time. The stem cell and mouse models I engineer during my K99 phase will be foundational for my R00 phase
and beyond where I will study progenitor cell dynamics during mammalian development using both cutting-edge
in vitro and in vivo model systems. I aim to study how the behaviors and histories of single cells lead to complex
cell states and characteristics. This work will provide a foundation for my future research program as an
independent investigator at a major research institution where I will use the spatially-resolved cell state and
lineage maps of progenitor cellular dynamics in normal development that I generate through this K99/R00 award
to understand how these same processes go awry in developmental disorders and diseases. This work that may
unlock a new era of quantitative genomics in developmental biology and guide future translational research.

Public health relevance
Project Narrative Genetic, epigenetic, and environmental factors drive the coordinated non-deterministic, programs of progenitor cell division and diversification that define mammalian development. This proposal describes the use of cutting- edge, paired imaging- and sequencing-based cell state and lineage recording technologies to describe and probe progenitor cell dynamics during mammalian development using both in vitro and in vivo model systems. Developing a quantitative framework of understanding cell fate determination and tissue patterning will provide novel insights into developmental programs in health and disease.